UPenn - Admin Core

Summary - Administrative Core
Scientific and administrative leadership and effective program project management of the IPCAVD is the goal
of Administrative Core (Core A). The core will oversee scientific progress relative to project aims and
milestones and lead scientific efforts. It will coordinate financial management, research program management,
regulatory compliance and reporting functions. In addition to coordinating these activities, the Administrative
Core will be responsible for promoting and documenting all aspects of scientific, IACUC and financial
regulatory compliance at University of Pennsylvania (Penn) and subcontracting institutions. Staff on this core
are located within the administrative offices of Dr. Andrabi, thus taking advantage of a highly experienced and
integrated management team. Penn provides infrastructure support for administration, information technology,
IACUC oversight and compliance, and human resources, and also provides dedicated pre- and post-award
units to facilitate administrative and fiduciary compliance. Penn will provide this support for the IPCAVD. A
highly functional administrative core will contribute to and facilitate the successful advancement of the
proposed science. Specific aims of Admin Core are to: (i) provide scientific and administrative leadership and
program coordination; (ii) ensure timely financial accounting and reporting; (iii) ensure regulatory compliance
with all institutional and federal research guidelines; and (iv) develop and implement an IPCAVD
communications and data sharing plan.